Core A - Administrative Core

PROJECT ABSTRACT - CORE A (ADMINISTRATIVE CORE)
The Administrative Core (Core A) will serve as a central entity to manage, coordinate, and supervise the
Washington University (WashU) CCHI center’s mission. The goal of the Core is to provide administrative support
and oversight of the research activities performed by the Projects and Scientific Cores, and to ensure successful
execution of the center’s missions. The following key activities will be performed by Core A: (1) Grant
management for the WashU CCHI through facilitating and ensuring regular and frequent communication
between Projects and Cores to ensure a vibrant collaborative environment, as well as assistance in the
preparation and submission of budgetary and scientific documents to the NIH. (2) Fiscal oversight and budgetary
support for the overall program, including the management of subcontracts. (3) Development and deployment of
a data management plan for the integration of information from different Projects and Cores and to ensure timely
and comprehensive data deposition into NIH-recommended/approved public repositories. (4) Development and
implementation of a conflict resolution plan, should it be necessary. A group of senior faculty members who are
not directly linked to the Projects or Scientific Cores has been recruited to serve as mediators. (5) Support of
communication with other CCHI entities and outside collaborators. (6) Regular communication with the NIAID
program officer and other NIAID staff, coordination of reports to the NIH, and oversight to ensure compliance
with NIH and local institutional requirements. To achieve these objectives and support a highly collaborative
environment, the Administrative Core will coordinate formal monthly meetings between Program participants
(Program Directors, Project and Core Leaders and Key Personnel) under the guidance of the Program Directors.
Participants in these meetings will be responsible for sharing data, evaluating progress, and planning further
steps as they relate to the specific goals of the program and aims of individual projects. Each meeting will include
a general discussion of results, goals, and progress, as well as a forum for discussion of key decisions and
initiatives. Additionally, the Administrative Core will plan annual site meetings, which will provide an opportunity
for all research project PIs and key trainees to present progress and receive guidance from our External Advisory
Committee.